Racial/Ethnic Disparities in Heart Failure: A Cross Cohort Collaboration

ABSTRACT
Heart failure (HF), and its subtypes defined by preserved (HFpEF), reduced (HFrEF) or mid-range (HFmrEF)
ejection fraction are a major and growing public health problem. The long term goal of this project is to better
understand the health disparities regarding HF and define effective preventive measures that may reduce
these disparities. We propose to pool data from 10 large longitudinal cohort studies to examine race/ethnic
and sex disparities in developing HF, its subtypes, and its prognosis. The harmonized data will include over
130,028 men and women with over 8975 similarly-adjudicated prospective HF outcomes, representing a wide
spectrum of ages, race/ethnicities, and geographic regions of the United States. This cross-cohort
collaboration will provide a unique opportunity to conduct a comprehensive evaluation of sex and racial/ethnic
health disparities in HF. Causal mediation analysis techniques will be used to estimate the degree to which
single and multi-factor lifestyle and clinical interventions could potentially reduce health disparities in HF. In our
phenomapping aim, we will define unique clinically relevant phenotypes of HF based upon cohort data that is
also commonly present in medical records for enhanced generalizability, including age, race/ethnicity, sex,
clinical signs, symptoms, biomarkers, ejection fraction, physiologic measures, and co-morbidities; we will also
evaluate HF phenotype associations with CVD and all-cause mortality.

Public health relevance
NARRATIVE This Racial/Ethnic Disparities in Heart Failure: A Cross-Cohort Collaboration study will evaluate the magnitude and potential causes of racial/ethnic and sex disparities in incident heart failure and its subtypes and their prognosis in over 130,000 men and women from 10 pooled cohorts. We will evaluate the impact of hypothetical lifestyle and clinical risk factors interventions on reducing the racial/ethnic disparities in developing HF. In addition using unsupervised machine learning phenomapping techniques, we will evaluate subtypes of HF and their prognosis, including models stratified by race/ethnicity.